AI-Powered MRI Quality Control and Artifact Correction for Multi-Site Studies

AI-Powered MRI Quality Control and Artifact Correction for Multi-Site Studies
Abstract
Magnetic resonance imaging (MRI), while commonly employed to investigate brain structure and function, is
susceptible to imaging artifacts caused for instance by eye and head motion, hemodynamic changes, and mag-
netic field inhomogeneities. Identifying images with questionable quality, correcting for artifacts, and discarding
unusable images reduce biases in subsequent analyses, and therefore help avoid erroneous conclusions. In
this project, we will develop computational tools, powered by artificial intelligence (AI), for image quality assess-
ment (IQA) and retrospective artifact correction (RAC), catering to large-scale studies involving multiple imaging
centers.
In Aim 1, we will develop a deep learning framework for automatic, objective, fast, and accurate IQA of structural
MRI data. IQA is typically performed via visual inspection by MRI technologists and can be time-consuming,
subjective, and error-prone. Our method will complete IQA in milliseconds with high sensitivity and specificity. It
will be designed to be easily trainable with a small amount of annotated data via semi-supervised learning. It can
be used immediately after each scan to determine whether the acquired data are usable and whether re-scan is
necessary. It can also be used in post-acquisition data curation to automatically identify usable images from huge
image datasets. We will also develop a deep learning framework to rapidly generate derivatives, such as cortical
surfaces, for inspection to ensure sufficient image quality for downstream analyses. In Aim 2, we will develop a
novel RAC method to remove artifacts without requiring modification of sequences or mounting of motion markers.
Existing RAC neural networks are typically trained in a supervised manner, requiring the scanning of the same
subjects motionless and with deliberate motions. In contrast, our RAC method will be based on unsupervised
learning, simply requiring the user to provide for training a set of clean and corrupted images, which can be from
different individuals. Our method is therefore practical with considerably better adaptability. In Aim 3, we will
develop techniques that will allow the methods developed in Aims 1 and 2 to be adapted to and optimized for
different imaging centers, MRI scanners, and imaging protocols without requiring explicit exchange of imaging
data across sites, which often requires data sharing agreements between institutions. The techniques developed
in this aim will help overcome data sharing challenges for site-optimized IQA and RAC.
Successful completion of this project will allow image quality assurance to be done automatically in large-scale,
multi-site, and longitudinal studies, and increase the amount of usable data for improving statistical power.

Public health relevance
Project Narrative This project will equip neuroscience researchers, radiologists, MRI technologists, and study coordinators with au- tomatic, objective, fast, and accurate tools for image quality assessment so that timely decisions for re-scans can be made to improve the likelihood of collecting usable structural MRI data of sufficient sample size for subsequent analyses. Our tools will allow (i) high-speed image quality assessment with high specificity and sensitivity, (ii) ret- rospective artifact correction without the need for modification of pulse sequences or mounting of motion markers, and (iii) method generalizability and optimality for multiple sites, scanners, and imaging protocols without explicit data sharing. Successful completion of this project will allow image quality assurance to be done automatically in large-scale, multi-site, and longitudinal studies, and increase the amount of usable data for improving statistical power.